2024 Myelin Gordon Research Conference and Seminar

PROJECT SUMMARY
This application is to request support for the 2024 Gordon Research Seminar (GRS; March 16-17) and
Conference (GRC; March 17-22) on Myelin to be held in Ventura, California, USA. The goal of these
conferences is to provide an active forum for the exchange of results at the cutting edge of myelin
development, physiology, pathology, and treatment. This meeting uniquely focuses on central and peripheral
myelin and is timely given the growing interest in myelin biology and human disease and major advances since
the last meeting in 2022. We have chosen as a theme for this conference “Dynamism and Life-Long Plasticity
of Myelin Producing Cells in Health and Disease” to reflect the major shift over the past few years from
considering myelin as a relatively static structure to the new view of myelin as a dynamic structure throughout
the lifetime of the organism. This dynamism and the plasticity of Schwann Cells and oligodendrocytes impacts
normal myelin-axonal function as well as in diseases such as Multiple Sclerosis, Alzheimer’s Disease,
peripheral neuropathies, and after injury, including in developmental disorders, and in the adult. We have also
organized sessions to reflect dynamic glial-to-glia interactions and glial–neuronal interactions that influence
normal myelin development, disease progression, and repair in the CNS and PNS. Together, the 2022 Myelin
GRC “Myelin: Dynamism and Life-Long Plasticity of Myelin Producing Cells in Health and Disease and the
GRS “Navigating Myelin Plasticity: A Roadmap through Health and Disease” will: 1) assemble an international
meeting of academic scientists, clinician/scientists, and industry scientists engaged in studies of myelination
and myelin repair; 2) discuss new and exciting developments in the field by selecting presenters who will
largely present unpublished data and by reserving presentation slots for talks selected from the abstracts; 3)
promote collaborative interactions to accelerate the pace of discovery to treat diseases of myelin; 4) provide an
opportunity for junior attendees of diverse backgrounds to present their work, interact with other scientists, and
promote collaborative interactions among all participants.

Public health relevance
PROJECT NARRATIVE The critical importance of myelin for proper nervous system function is underscored by the devastating symptoms in diseases in which it is disrupted, including multiple sclerosis, leukodystrophies, and peripheral neuropathies that affect millions of Americans. It is also now becoming clear that myelin is a dynamic rather than a static structure that modulates neural plasticity in the healthy as well as diseased and injured central and peripheral nervous systems. The 2024 Myelin Gordon Research Conference and Seminar will bring together experts and trainees in the field of myelinating glial cell biology and repair to provide a forum to highlight recent advances in the field with a focus on themes of dynamism and plasticity.